CRISPR gene therapies targeting tau in Alzheimer's disease and tauopathies

PROJECT SUMMARY / ABSTRACT
The MAPT gene encoding the tau protein is an ideal target for Alzheimer’s disease (AD) therapeutics since it
forms hallmark pathology in all AD patients. In mice, tau aggregation drives disease progression, while
depleting tau leads to cognitive improvements, suggesting targeting tau may benefit human patients as well. A
major question has been how to achieve this goal. CRISPR technology (Clustered Regularly Interspaced Short
Palindromic Repeats) has blossomed in recent years, and we can now leverage this approach to specifically
deplete tau in neurons. By targeting different tau isoforms with site-specific guide RNAs of interest, one can
conceivably target the specific tau variants that are present in 3R-tauopathies (e.g., Pick’s disease), 4R
tauopathies (e.g., corticobasal syndrome), or mixed 3R/4R tauopathies (e.g., AD patients). Thus, we turned to
a newly developed CRISPR/Cas13 technology, which allows targeting and depletion of RNA transcripts rather
than DNA itself, the latter of which can have unwanted effects on the genome including DNA damage and even
tumorigenesis. CRISPR/Cas13 technology could provide new opportunities for therapeutic tau reduction and
potentially overcome many of the limitations that have plagued tau depletion strategies. In fact, our preliminary
findings show that we can computationally predict which guides will successfully target and deplete tau, and
we demonstrated this in a human cell line and primary human neurons, suggesting we have found an optimal
pipeline for guide prediction, development, and validation. Therefore, we have an exciting opportunity to
develop an effective, non-invasive tool for tau gene therapy in the nervous system (CNS). In Aim-1, we will
develop and refine the CRISPR/Cas13 system to target tau and will comprehensively identify the most optimal
guide RNAs that target either 3R-tau, 4R-tau, or total tau. We will deliver those guides to neurons and
determine their effectiveness and ability to restore normal neuronal function. In Aim-2, we will perform
preclinical efficacy testing and determine whether our most optimal CRISPR/Cas13 complexes have
therapeutic potential in AD model mice. By delivering tau-targeting guides peripherally using brain-penetrant
AAV methods, we will evaluate their therapeutic impact by performing a battery of biochemical, histological,
and behavioral studies at either early (preventative) or late (therapeutic) stages of disease progression. This
study is innovative and significant since it will both develop the CRISPR technology needed to target tau, and
also advance gene therapy approaches to deplete tau in humans including AD and other dementia patients.
The clear implications are that targeting and reducing tau levels, even modestly, could provide a new treatment
modality for dementia patients.

Public health relevance
PROJECT NARRATIVE Tau reduction has emerged as a highly promising strategy to alleviate pathology and associated cognitive decline, not just in AD patients, but in a wide spectrum of tauopathy patients. CRISPR/Cas13 strategies will be developed, validated in vitro, and then delivered in vivo into AD model mice using AAV delivery approaches for efficient brain targeting of the CRISPR machinery with a single intravenous injection. Reducing tau levels, even modestly, using a brain-specific tau CRISPR approach could provide a new treatment modality for AD and related dementia patients.